Investigation of Prognostic Factors in Childhood-Onset AIS: Role of Stroke Subtyp

DESCRIPTION (provided by applicant): Arterial ischemic stroke (AIS) is a common and devastating disorder of childhood. In spite of this, there is little evidence regarding etiology or outcomes with which to inform treatment. This proposal aims to support the early career development of an academic pediatric neurologist focusing upon the investigation of prognostic factors in childhood-onset AIS. Specifically, we are investigating the role of stroke subtype and biomarkers upon the risk of recurrent stroke. Preliminary results suggest that acutely elevated biomarkers of hypercoagulability are likely associated with specific subtypes in childhood-onset AIS. Further, these biomarkers may be prognostic or recurrent AIS and/or adverse neurological outcome. Certain stroke subtypes, such as arteriopathy, are also associated with recurrent AIS. Therefore, we seek to explore the combined prognostic significance of subtype and biomarkers of hypercoagulability upon recurrent AIS in children with stroke. To that end, our initial aim is to confirm the reliability of a consensus based classification system in childhood- onset AIS. This analysis will be performed as an ancillary study of an established NIH database of over 100 consecutively enrolled patients with childhood-onset AIS. In a separate, four-center cohort of prospectively enrolled children with childhood onset AIS, we will evaluate the relationship between stroke subtype and acutely elevated biomarkers of hypercoagulability. Finally, we will evaluate the prognostic significance of biomarkers of hypercoagulability, stroke subtype, and systemic inflammation for recurrent cerebrovascular events in childhood-onset AIS.

Public health relevance
PUBLIC HEALTH RELEVANCE: Childhood stroke is a poorly understood disease. The most prevalent risk factors identified to date include stroke subtype and coagulation abnormalities. The systematic collection of the proposed biomarkers may provide insight into 1) the pathophysiology of childhood stroke, 2) the prediction of recurrent stroke, and 3) the identification of patients who need more aggressive therapies. Project Narrative Childhood stroke is a poorly understood disease. The most prevalent risk factors identified to date include stroke subtype and coagulation abnormalities. The systematic collection of the proposed biomarkers may provide insight into 1) the pathophysiology of childhood stroke, 2) the prediction of recurrent stroke, and 3) the identification of patients who need more aggressive therapies. __SpecificAimsTextDelimiter__ 10. Specific Aims: Arterial ischemic stroke (AIS) is an increasingly recognized and often devastating disorder of childhood, occurring in 2-8/100,000 children. 10-12 Common etiologies in children include cardioembolism, sickle cell disease, arterial dissection, and idiopathic arteriopathies (characterized by focal cerebral arterial stenosis). Hypercoagulable states are also common.2 The mainstay of therapy is anti-platelet therapy, with anticoagulation reserved for selected circumstances. Long-term outcome is poor, with over 70% of children developing chronic neurological deficits, and up to 37% experiencing recurrent cerebrovascular events.4,13 While much progress has been made in recent years toward understanding risk factors for childhood- onset AIS, the ability to reliably predict childhood-onset AIS remains limited to sickle cell disease. Primary prevention with chronic transfusion in sickle cell patients with abnormal transcranial Dopplers provides a powerful example of risk-stratified therapy in childhood-onset AIS. The development of future risk-stratified treatment strategies in other subtypes of childhood-onset AIS is dependent upon the identification of prognostic factors. Early evidence suggests that children with arteriopathic stroke subtype or hypercoagulable states are at increased risk of recurrent cerebrovascular events.12,14,15 However, in contrast to extensive literature on prognostic biomarkers (particularly in the areas of hypercoagulability and inflammation) in adult AIS, this knowledge is lacking in childhood-onset AIS. Evidence in adult and childhood-onset AIS suggests that biomarkers, such as D-dimer, are often subtype specific.1,16 Further efforts to thoughtfully investigate the prognostic utility of biomarkers in childhood- onset AIS therefore require a standardized and reliable classification system for childhood-onset AIS. At present, no such classification system exists. However, in collaboration with my proposed K23 secondary mentors, Drs. Rebecca Ichord and Gabrielle deVeber, I have developed a classification system-the Childhood AIS Standardized Classification and Diagnostic Evaluation (CASCADE) criteria. With funding from an institutional KL2 award, I have begun the investigation of hypercoagulable biomarkers and subtype in childhood-onset AIS, leading to the first publication in this area.1 This research builds upon previous work by my mentor Dr. Marilyn Manco-Johnson,10 which illustrates the prognostic role of D-dimer in pediatric venous thromboembolism. It is my belief that D-dimer will also have prognostic importance for risk of recurrent cerebrovascular events in childhood-onset AIS, and its predictive capacity will be independent of systemic inflammation. My goal- and the purpose of this K23 proposal- is to attain the research experience and scientific skills needed to become a leader in the field of prognostic factors and classification in childhood-onset AIS, leading to the investigation of targeted therapeutic strategies in childhood-onset AIS (Figure 1). Efforts to establish key prognostic indicators in childhood-onset AIS are critical in order to direct future risk-stratified approaches to therapy and the development of randomized controlled trials aimed at improving outcomes in this disease. This approach is supported by the NHLBI strategic plan, which states that biomarkers "can be used to subdivide related diseases into clinically meaningful classes to achieve early diagnosis, to predict disease progression or regression, and to anticipate the occurrence of desirable or adverse therapeutic outcomes." In addition, studying candidate biomarkers and establishing a consensus- based classification will expand our understanding of the interplay between coagulation, inflammation and stroke subtype in the pathogenesis of childhood-onset AIS. The hypotheses and specific aims of the present application are as follows: Specific Aim 1: To confirm the reliability of a consensus based classification system in childhood-onset AIS, the CASCADE criteria. Hypothesis 1. The use of CASCADE criteria for stroke subtype classification in children will provide greater inter-rater reliability than current ad-hoc methods of classification in this disease. Specific Aim 2: To evaluate the relationship between stroke subtype and elevated biomarkers of hypercoagulability in the acute phase of childhood-onset AIS. Hypothesis 2. In the acute phase of childhood-onset AIS, D-dimer levels differ significantly across major CASCADE subtypes. Specific Aim 3: To evaluate the prognostic significance of biomarkers of hypercoagulability, stroke subtype, and systemic inflammation for recurrent cerebrovascular events in childhood-onset AIS. Hypothesis 3a. Risk of recurrent cerebrovascular events is significantly increased among childhood- onset AIS patients who have acutely elevated D-dimer levels in a Kaplan-Meier survival analysis. Hypothesis 3b. In a Cox proportional hazards model, one-year recurrence risk remains significantly increased among childhood-onset AIS patients who have acutely elevated D-dimer levels, independent of CASCADE stroke subtype or systemic inflammation (as measured by high sensitivity C-Reactive Protein [hsCRP]). Figure 1. Investigation of Prognostic Factors in Childhood-onset AIS: Role of Stroke Subtype and Biomarkers Hyper- Inflammatory coagulable Biomarkers Biomarkers Aim 2 Stroke Subtype (CASCADE) Aim 1 KL2 K23 Risk Stratification High Risk of Recurrent Cerebrovascular Events Aim 3 Low Risk of Recurrent Cerebrovascular Events Therapeutic Choices Aggressive, Targeted Therapies Safer, Less Aggressive Therapies R-level Funding